2'3'DIDEOXYINOSINE IN PATIENTS WITH AIDS AND AIDS RELATED COMPLEX

This study evaluates the pharmacokinetic toxicity and therapeutic efficacy of escalating doses of dideoxyinosine (ddI) given once a day for the treatment of A and ARC. Amendments have included a pharmacokinetic study of ddI with Gancyclovir in patients with CMV infections and AIDS. Patients are followed for the effects of longterm therapy on ddI.